Alcohol, Immunosenescence, & Senodynamics in People with HIV

LSUHSC CARC RC4
People with HIV (PWH) who achieve viral suppression have a near normal lifespan.
However, the precocious onset of geriatric comorbidities has emerged as the new face of
the HIV endemic. Alcohol use is highly prevalent in PWH and is associated with many of
these comorbidities. We have reported that alcohol use over the lifespan in PWH
correlates with frailty and biological age in cross-sectional analyses of participants in the
New Orleans Alcohol Use in HIV (NOAH) Study. Our translational studies have focused
on senescent T cells as a mechanism underlying alcohol’s impact on frailty. Senescent T
cells are enriched in the CD8+CD28- population. Functionally, they are hyporesponsive to
novel antigens and display a Senescence-Associated Secretory Phenotype (SASP),
producing pro-inflammatory mediators that promote organ dysfunction in the context of
biological aging. Important findings from RC4 regarding alcohol’s effects on T cells in
PWH include: [i] Alcohol use increases the prevalence of activated senescent
(CD8+CD28-CD38+) T cells; [ii] Intestinal dysbiosis mediates alcohol-induced increases
in these T cells; [iii] Alcohol induces changes in intestinal and plasma metabolites; [iv]
Alcohol increases glycolysis, impairs oxidative phosphorylation and mitochondrial repair,
and promotes a pro-inflammatory phenotype in T cells; [v] Alcohol-linked circulating proinflammatory
mediators correlate with activated senescent T cells; and [vi] Senescent T
cells display alcohol-exaggerated caspase 1 activation.
We hypothesize that caspase 1 activation contributes to the functional
consequences of alcohol exposure on senescent CD8+ T cells. Our vision is that
understanding these mechanisms will uncover therapeutic targets and inform
approaches to mitigate the accelerated biological aging and frailty associated with
alcohol use in PWH. Our studies will identify mechanisms contributing to alcoholassociated
T cell senescence in PWH. Because our preliminary data generated in
collaboration with RC2 show that metformin attenuates alcohol-induced increases in
senescent T cells, we will test the senoprotective effects of metformin in the chronic-binge
alcohol simian immunodeficiency virus (CBA/SIV) non-human primate (NHP) model and
in the NOAH Study participants, employing a bidirectional, mechanistic translational
approach. Metformin is a fundamental therapeutic for type 2 diabetes that targets multiple
pathways associated with biological aging and has shown promise as a geroprotective in
preclinical models. Two Specific Aims are proposed: Specific Aim 1: To identify
bioenergetic mechanisms by which alcohol increases senescent CD8+ T cells; Specific
Aim 2: To identify alcohol-mediated mechanisms that contribute to senescent CD8+ T cell
production of pro-inflammatory mediators (SASP) in PWH. This project will provide an
enhanced understanding of the mechanisms by which alcohol use promotes a senescent
immunophenotype in PWH. Our data will inform novel approaches to mitigating the
geriatric comorbidities in PWH that use alcohol.

Public health relevance
People with HIV (PWH) have an early onset of frailty and cellular aging (senescence) that is associated with alcohol use. This project will identify the mechanisms by which alcohol increases the number of senescent immune cells and determine how alcohol changes the function of these cells. Understanding alcohol’s impact on senescent immune cells will inform new approaches to reducing frailty in PWH that use alcohol.